Investigation of Social and Behavioral Drivers of HIV Risk Among South African Adolescent Girls and Young Women

Project Summary/Abstract
South Africa has the greatest burden of HIV infection in the world, and South African adolescent girls and
young women (SA-AGYW) ages 15-24 are at greatest risk. Mental health distress (anxiety, trauma,
depression) and intimate partner violence (IPV) are implicated as drivers of HIV, yet few studies have
assessed the combined effects of mental health and IPV on SA-AGYW sexual risk behavior (early sexual
debut, no condom use at last sex, multiple sexual partners). Notably, high warmth and frequent communication
about sexual topics between female caregivers and AGYW are associated with reduced AGYW sexual risk
behavior, but few studies have examined the impact of female caregiver-AGYW communication and warmth in
the presence of mental health distress and IPV on AGYW sexual risk taking. The proposed fellowship will
provide much needed training to prepare me for a career as a physician scientist with a global health program
of research. Guided by an expert mentorship team to oversee my training activities, I will gain skills in
adolescent and young adult mental health distress, sexual risk behaviors, and their roles as drivers of HIV
infection, HIV epidemiology, advanced qualitative research, and complete my medical and PhD degrees. I will
use these new skills to carry out a mixed methods research study integrating quantitative and qualitative
methods to accomplish two specific aims. In Aim 1, I will conduct secondary analyses of baseline data from a
large HIV prevention intervention involving SA-AGYW and their female caregivers (IMARA-SA). Analyses of
642 AGYW will examine mental health distress, IPV, and AGYW-caregiver warmth and communication as
drivers of AGYW sexually transmitted infections, including HIV. Preliminary data from the parent study
revealed high rates mental health distress and IPV. I hypothesize that increased warmth and communication
between AGYW and female caregivers will decrease the association between mental health distress and
sexual risk behaviors even in the presence of IPV. In Aim 2, I will supplement the quantitative analysis with 20-
30 qualitative interviews with SA-AGYW with experiences of IPV. I will purposively select participants from the
parent study who have completed the 12-month follow up and reported IPV. Interviews will offer new insight
into the impact of female caregiver communication about addressing experiences of IPV and sexual risk
behavior. The findings from aims 1 and 2 will inform interventions to improve the SA-AGYW mental health,
lessen IPV exposure, and strengthen sexual and reproductive health. Mentorship provided by an experienced
team with a long history of collaboration will ensure excellent training, extensive opportunities to publish in high
impact journals and present at international scientific conferences, and exposure to colleagues through
networking. This F30 fellowship will provide a well-rounded education that empowers me to become a
physician-scientist with a program of research focused on AGYW sexual and reproductive health.

Public health relevance
Project Narrative Elucidating the individual, social, and cultural factors that contribute to South African adolescent girls' and young women's (SAAGYW) sexual risk behavior is essential for informing evidence-based HIV and STI prevention interventions. The proposed mixed methods study will provide a multifaceted exploration of the association between mental health distress and SAAGYW sexual risk behavior, and the effects of intimate partner violence and female caregiver warmth and communication on this association. Findings from this study will inform research programs focused on addressing the effects of mental health distress, intimate partner violence, and prevention of HIV and STI among South African adolescent girls and young women by including female caregivers as resources of prevention support.